Functional consequences of the interactions between tau protein and opioids

PROJECT SUMMARY
The opioid epidemic is a persistent public health crisis that has been worsened by the COVID19 pandemic.
Efforts to curtail this epidemic have had minimal success in halting its continued progression. There is a critical
need to more fully understand the neurobiology of opioid use disorder so that highly novel therapeutics can be
developed. Recent clinical and preclinical studies have found that opioid use increases the levels of phosphory-
lated tau protein in the brain, especially in the prefrontal cortex. The prefrontal cortex plays a significant role in
the control of opioid use. Hyperphosphorylated tau is a hallmark of neurodegenerative tauopathy-related dis-
eases such as Alzheimer’s Disease and frontotemporal dementia. However, opioid use does not appear to be a
major predisposing factor in the development of these diseases. This begs the question of whether opioid-in-
duced increases in phosphorylated tau are a simple byproduct of opioid use with no significant role in brain
health, or if this increase has significant biological relevance for mediating the neurobehavioral consequences
of opioid use. Focusing research efforts on whether opioid use produces neurodegenerative diseases may lead
to a missed opportunity to explore a non-neurodegenerative role for opioid-induced changes in tau biology. It is
known that hyperphosphorylated tau can and tau oligomerization alter neurotransmission long before tau-related
pathology is observable. Therefore, we reason that opioid-induced increases in phosphorylated tau and tau oli-
gomerization may alter prefrontal cortical neurotransmission in the absence of any overt pathology. This project
proposal tests the hypothesis that opioids produce enhanced tau phosphorylation and oligomerization in the
prefrontal cortex leading to synaptic dysfunction and elevated opioid consumption. We will focus on the opioid
oxycodone in this project due its long-term use to treat pain as well as its common misuse in those with opioid
use disorder. We will use a multidisciplinary approach to test for a causative role for prefrontal cortical tau in
producing synaptic dysfunction and enhancing oxycodone consumption. This project is high-risk, high-reward. It
is conceivable that opioid-induced changes in tau have nothing to do with synaptic changes or oxycodone con-
sumption. However, if there is a connection between opioid-induced changes in tau biology and synaptic
changes and opioid use, then this will be a paradigm shift for the opioid research field. In the future, after some
additional exploration, we may be able to leverage therapeutics originally designed to treat neurodegenerative
tauopathies to treat opioid use disorder. This would be an entirely new avenue for combatting the opioid epi-
demic.

Public health relevance
PROJECT NARRATIVE Opioid use increases the levels of phosphorylated tau protein in the brain, which is a classical marker of tauopa- thy neurodegenerative diseases, yet opioid use is not known to produce classical tau-related neurodegeneration pathology. Therefore, it is not clear if opioid-induced changes in tau are a byproduct of opioid use that has no independent effect on neurobehavioral function or if these changes in tau contribute to the effect of opioids on neural function and opioid consumption-related behaviors. This high-risk, high-reward project tests the hypothe- sis that opioids increase tau expression, phosphorylation, and aggregation in the prefrontal cortex leading to synaptic dysfunction and elevated oxycodone consumption.